Development of a Small Molecule Inhibitor of Fortilin for Atherosclerosis Treatment and Prevention

Project Summary
Project Title: Development of a Small Molecule Inhibitor of Fortilin for Atherosclerosis Treatment and
Prevention. Atherosclerosis affects more than 18 million Americans and is a major cause of cardiovascular
diseases and acute cardiovascular events, such as heart attack and stroke. Current interventions include
changes to diet and exercise, smoking cessation, and treatment with statins, but many patients struggle to
adhere to lifestyle interventions and can experience significant side effects while taking statins. Although lipid
lowering drugs have benefited patients with atherosclerosis, the idea that lipid lowering halts the progression of
atherosclerosis is not valid because factors other than hypercholesterolemia have been shown to promote
atherosclerosis. Therefore, there is a clear need for novel therapeutics that can directly inhibit plaque formation
through a mechanism other than lipid lowering. Fortiscience, Inc. is developing an alternative therapeutic
approach that inhibits fortilin, a key protein involved in atherosclerotic plaque formation. Fortilin protects
macrophages against apoptosis in atherosclerotic intima, allowing them to proliferate and produce inflammatory
cytokines. Strikingly, global knockdown of fortilin protects hypercholesterolemic mice against atherosclerosis
without lowering cholesterol. Three small molecular weight compounds identified in preliminary work at the
University of Washington have been shown to have activity in relevant in vitro and in vivo models, and these
compounds have been used as the basis for designing and synthesizing 52 additional compounds with higher
binding affinity through a medicinal chemistry approach. In this Phase I STTR project, to be conducted in
collaboration with the University of Washington and the University of Notre Dame, 10 prioritized compounds will
be evaluated using cell-based fortilin degradation and foam cell formation assays to assess activity (measuring
the EC50) and cell death assays to determine cytotoxicity (LC50). Based on an analysis of the structure–activity
relationship for these compounds, computational virtual docking assays will be performed to design and
produce 3-5 new compounds with improved fortilin binding affinity. The binding affinity, activity, toxicity, and
stability of these compounds will then be measured, and the data will be used to select a lead compound with a
single-nanomolar dissociation constant, a lower EC50 value than the previous best-performing compound, and
low clearance in liver microsome assays (CLint below 15 mL min-1kg-1). Further, pharmacokinetic and toxicity
profiles will be determined for the lead compound in a 15-day oral dose range finding study in C57BL/6 mice.
Finally, the anti-atherosclerotic activity of the lead compound will be determined in the aortae of
hypercholesterolemic mice following 12 weeks of oral administration, with the goal of achieving a 50%
reduction in atherosclerosis. This work is designed to provide the necessary proof-of-concept data to support
further pre-clinical studies in Phase II and a future first-in-human clinical trial to establish the safety of the drug.

Public health relevance
PROJECT NARRATIVE Current treatment approaches that are designed to prevent atherosclerosis progression by reducing LDL cholesterol levels often fail to prevent the growth and evolution of atherosclerotic plaques in patients’ arteries. Fortiscience, Inc. is taking a novel approach to treating atherosclerosis by developing a drug that inhibits fortilin, a key protein involved in the survival of macrophages, which contribute to plaque formation and inflammation. This novel drug, which is intended to prevent plaque progression, will provide an alternative to lipid-lowering therapies and reduce the risk of life-threatening cardiovascular events in patients with atherosclerosis.